Novel mechanism for sex differences in hearing loss

Project Summary / Abstract
There is growing awareness of the importance of sex differences in auditory function and disorders. Large-scale
clinical studies have revealed a strong sex bias in hearing loss prevalence. While females have a lower overall
prevalence of hearing loss, 8.3 million women have hearing impairment, and 1.67 million begin experiencing
hearing loss during their middle age. Hearing loss in females worsens after menopause. Moreover, female
hearing levels are more variable, suggesting disease conditions that affect subpopulations of females, increasing
their vulnerability to certain otologic disorders. Autoimmune disorders preferentially affect women, leading to a
higher prevalence of immune-related hearing impairment. Female-related hearing loss typically begins around
the middle age and affects the low- and mid-frequencies essential for perceiving speech. At present, the
underlying mechanisms for female hearing loss are poorly understood. The lack of understanding has prevented
the development of diagnostic tools to determine the underlying causes of sex-dependent susceptibility to
hearing loss. We recently identified a lectin family protein, galectin-3, in the cochlea. This β-galactoside-binding
protein has been involved in various biological processes, including immune functions. It also has a vital role in
inflammatory disorders. Our pilot observations have shown that galectin-3 is highly expressed in cochlear
immune cells and supporting cells, both being immune-competent cells. This protein participates in cochlear
inflammatory responses to age-related and noise-induced hearing loss. Our analysis revealed that targeted
disruption of galectin-3-coding gene, Lgals3, increases female susceptibility to age-related cochlear
degeneration. Identification of galectin-3 as an important sex-relevant immune molecule provides us with a
powerful tool to investigate the role of immune-mediated activities in female auditory dysfunction. The long-term
goal of our research is to determine the molecular mechanisms underlying sex differences in otologic disorders.
The proposed research aims to use galectin-3 as a gateway to identify female-linked molecules and determine
how these molecules interact with female hormones to affect female cochlear homeostasis and susceptibility to
hearing disorders. Specifically, we will 1) determine the role of galectin-3 in maintaining auditory function and
cochlear integrity, 2) determine immune mechanisms underlying the female susceptibility to galectin-3
deficiency, and 3) determine female hormonal regulation of cochlear gene expression. Our proposed study will
address a clinically relevant but still understudied research topic, female hearing loss. Identifying molecules
critical to female hearing has great potential for clinical translation. The knowledge gained from the proposed
studies can guide future efforts to identify female essential molecules in human ears, which will aid in identifying
clinically applicable biomarkers for revealing the underlying causes of female hearing loss. Ultimately, studying
the biological basis of sex differences will provide the foundation for developing sex-dependent therapies for
hearing loss.

Public health relevance
Project Narrative There is growing awareness of the importance of sex differences in the auditory system, particularly susceptibility to otological disorders. The proposed study will determine molecular mechanisms for female hearing loss. This study is relevant to public health because the knowledge gained from the studies will guide future clinical efforts to develop diagnostic tools for defining underlying causes of female hearing loss.